Native Hemodynamic Measurement as Feedback Control for Mechanical Cardiac Support

Abstract
Temporary Mechanical Circulatory Support (MCS) devices have been an effective means of
temporary support in patients for two indications: acute myocardial infarction (MI) with or without
cardiogenic shock (CS), and acute decompensated heart failure (HF). These ailments strike the
elderly the hardest and are simultaneously more prevalent as age progresses. Cardiogenic
shock after MI is more common in elderly patients than in the young, and HF has increasing
prevalence with age (60-79, 6% have HF, for over 80, 10% have HF). In these patients, a short-
term MCS device is a catheter delivered pump that can be placed in the LV, and pump blood
across the aortic valve, to help maintain forward flow while unloading the failing heart. The key
metric for optimizing the use of these devices includes a combination of pressure, and volume
measurement. While pressure is already commonly measured on-device, MCS devices on the
market today cannot estimate the total Cardiac Output of the heart, a key component of Cardiac
Power Output (CPO, CO x mean aortic pressure) which is now well accepted as the single most
important correlate of mortality in cardiogenic shock. Optimization of ongoing treatment as well
as when to wean the patient from the MCS device to transition them to recovery (or a more
permanent device) currently lacks a real-time, accurate measure of CO (necessary to calculate
CPO). We propose integrating a proven LV volume measurement (admittance-based
technology) capable of determining CO directly onto the MCS device, allowing the device to
actively change pump speed (and therefore effect CPO) to respond to changing patient
condition. In this phase 2 effort, BridgeSource Medical will demonstrate how admittance-based
technology can be redeveloped for application on existing MCS device platforms.

Public health relevance
Narrative Temporary Mechanical Circulatory Support (MCS) devices have a goal of assisting the failing heart to bridge a patient to recovery, or to a more durable ventricular pump. However, a key metric of optimal hemodynamic stabilization, the native cardiac output (CO) is not measured on these increasingly popular devices.